Investigations of drug encapsulation in polymer nanoparticles: Training undergraduate students in multidisciplinary research

Abstract
For several decades nanoparticle formulations of molecules used for diagnostics and/or therapy have been
intensively developed to improve and control their bioavailability and pharmacokinetics. This is particularly
important for the large number of new drugs developed that have poor solubility in water. A common form of
such formulations consists of small molecules of an active pharmaceutical ingredient (API) encapsulated in a
polymer nanoparticle carrier. Despite the advantages of this type of nanoparticle formulation for many
materials, there is a lack of predictive quantitative models for determining the optimum method, processing
conditions and excipients needed to effectively encapsulate a given API. Instead, much of the development
and optimization are based on qualitative and/or trial-and-error methods.
This proposal aims to address this by a systematic study of the encapsulation efficiency of small molecules into
polymer nanoparticles using the method of flash nanoprecipitation. This simple method, in which a solution is
rapidly mixed with a second, miscible solvent in which the API has poor solubility, yields nanoparticle
dispersions with sizes in the range of 10’s to 100’s of nanometers. It has several advantages, including ease of
scaleup, the possibility of incorporating multiple components into single particles, and the ability to use the
processing conditions to kinetically trap molecules that might otherwise not be encapsulated.
We propose to develop a general model for predicting the encapsulation efficiency of a given molecule into a
polymer nanoparticle based on the molecular properties of the API, polymer, and solvents and as a function of
the processing conditions such as concentration, mixing rates and temperature. Our model will be based on
both thermodynamics (partitioning of the molecules into the polymer phase due to non-specific van der Waals
interactions) and kinetics (trapping of molecules in the polymer due to the glass transition), as well as the
interplay between the two. The model will be tested using a range of molecules, polymers, and solvents by
measuring encapsulation efficiencies and effects of the small molecule on the particle size and morphology. A
second aim will be to apply this model to the development of various potentially useful systems. Finally, we will
use this project as an opportunity train undergraduate students in highly multidisciplinary research, exposing
students with backgrounds in physics to applications in biomedicine and giving biology or biochemistry
students experience in fundamental materials characterization.

Public health relevance
Encapsulating drugs in polymer nanoparticles is a common strategy for improving their bioavailability, but there is currently a significant gap in our fundamental understanding of the formation process, leaving much of the development and optimization reliant on qualitative assessments and trial-and-error methods. This project aims to develop a general model for the creation of drug-encapsulated nanoparticles while also providing valuable training opportunities for multiple undergraduate students in a highly multidisciplinary domain, thereby contributing to the education of future drug development researchers. Anticipated outcomes include the formulation of design principles that will serve as a blueprint for a diverse spectrum of nanoparticle drug formulations, addressing a wide array of medical conditions.